Elucidating Airborne SARS-CoV-2 Infectivity at Single Aerosol Resolution

PROJECT SUMMARY
In this emergency R21 effort we propose to implement a set of novel studies designed to improve our
fundamental understanding of SARS-CoV-2 aerobiology. Through a combination of theoretical, experimental,
and epidemiological data, there is emerging consensus that respiratory aerosols play a primary role in the
transmission of COVID-19. However, despite the importance of understanding the fundamental mechanisms
involved in the airborne transmission route, a number of basic questions central to SARS-CoV-2 aerobiology
remain unanswered. In particular, the distribution of SARS-CoV-2 particles within different aerosol size
populations has not yet been studied in detail, nor is there data available to predict the viability and infectivity of
individual airborne virus particles within different aerosol populations. Furthermore, it is not currently known
whether the virus tends to be uniformly distributed within a given aerosol population or clustered within a small
number of aerosol droplets, an essential question for understanding the quantum of infection for COVID-19
transmission. To address these challenges, we propose a novel analytical approach combining efficient sampling
of exhaled breath, high resolution fractionation of aerosol ensembles, and coupled analysis of inactive and
infective virus particles within the collected aerosol fractions through a combination of RT-PCR and viral plaque
assays. Significantly, aerosol fractionation will be performed using an Aerodynamic Aerosol Classifier as a
unique technology for isolating monodisperse aerosol populations. In addition, a new technique for discretizing
the collected aerosol particles will be implemented using a thermo-responsive hydrogel for aerosol deposition,
allowing the particles to be delivered to cell culture while remaining spatially isolated and elucidating virus
distribution and clustering within a given size fraction. The combined data sets resulting from the proposed
studies will provide a first view of the distribution and conformation of SARS-CoV-2 within respiratory aerosols,
and the relationships between aerosol properties (size, virus content, virus distribution, and clustering) and
downstream infectivity. We anticipate that the improved understanding of aerosolized virus infectivity emerging
from these studies will illuminate fundamental aspects of COVID-19 airborne transmission and allow us to identify
the quantum of infection associated with SARS-CoV-2, thus supporting accurate modeling of transmission
dynamics and guiding improved recommendations for PPE, room ventilation, and sanitation protocols to enhance
intervention and minimize transmission of the virus.

Public health relevance
PROJECT NARRATIVE There is growing evidence that COVID-19 is primarily transmitted by the airborne route, but significant questions about the remain about SARS-CoV-2 aerobiology. This project will implement a set of clinical studies using a novel technology platform designed to elucidate the distribution, clustering, and infectivity of SARS-CoV- 2 virus within exhaled breath aerosols, with the goal of enhancing our understanding of SARS-CoV-2 aerobiology and informing the design of improved approaches to mitigating viral spread.